Pathogenesis of infection in pancreatitis: from sterile inflammation to sepsis

PROJECT SUMMARY:
Acute pancreatitis (AP) affects @ 275,000/ year in the USA. AP starts suddenly and unpredictably as sterile
inflammation but in severe cases can get infected, resulting in sepsis, prolonged hospitalization and sometimes
death. Sepsis itself affects 1.5 million people /year in the USA, costs > $20 billion, results in 12-18% mortality
and has a lot in common with AP. While defined as an overwhelming response to infection, a large portion of
sepsis starts in sterile diseases like AP. AP has modelled the progression of sterile diseases to infection and
sepsis since sepsis was first defined in 1992. Both diseases are poorly understood, and neither has a specific
targeted therapy. Both diseases, when severe have distant organ failure, which we have shown to be due to
the excessive and unregulated lipolytic release of unsaturated fatty acids during AP. Unbound fatty acids (uFA)
refers to the small pool (<1%) of free fatty acids that are not bound to their main carrier, i.e. albumin, which is
frequently low in severe AP. Our preliminary data show that pancreatic lipases generate uFA which are
increased in the sera of severely septic patients. Additionally, uFA can rapidly incorporate into the membranes
of inflammatory cells, trigger injury and impair their function. Based on these we hypothesize that uFA
generated by pancreatic lipases cause inflammatory cell injury, impair bacterial clearance and result in sepsis
during AP. We propose to study the molecular mechanisms of how lipotoxic inflammatory cell injury causes
infections by using cell, animal models (Aim 2), and test the relevance of this in human AP, thus providing
evidence to support changes in clinical AP management (Aim 1).In Aim 1 we will determine the clinical
significance of lipotoxic inflammatory cell injury in clinical AP by determining the prognostic value of serum uFA
and inflammatory cell injury at admission for AP vs. at time of infection, along with studying the relationship
between type of uFA, nature of inflammatory injury with the type of infection. In Aim 2, we go on to determine
the mechanisms and consequences of lipotoxic inflammatory cell injury in AP using cell and animal models. To
do so we will study the dependence of inflammatory cell injury on pancreatic lipases and the lipid environment,
determine the role of impaired bacterial clearance, and explore the mechanisms by which lipotoxic
inflammatory cell injury occurs. By doing so, we hope to provide a broadly relevant, mechanistically sound,
therapeutically amenable, novel explanation for sepsis. This work would set a conceptual framework to
understand the pathogenesis of infection in sterile diseases (i.e. via uFA mediated inflammatory cell injury),
which is clinically relevant- i.e. explains why a drop in white counts may signal increased risk of infection such
as nosocomial infections and thus may not be always favorable. It can also provide improved diagnostic tools
based on flow-cytometry to interpret WBC counts, injury and risk of infection, and suggest therapeutic options
like the early replacement of albumin, prudent prophylactic antibiotic use, and targeting pancreatic lipases as
an approach to avert the progression of sterile AP to severe sepsis and death.

Public health relevance
PROJECT NARRATIVE: Based on unregulated lipolysis by pancreatic lipases generating unbound fatty acids causing inflammatory cell damage, thus impairing pathogen clearance; we will study how sterile acute pancreatitis(AP) gets infected and septic using cell, animal models (Aim 2), along with human measurements to determine relevance (Aim 1).